Bilevel positive airway pressure (BPAP) for severe pediatric asthma exacerbations: A randomized, controlled trial.

PROJECT SUMMARY/ABSTRACT
Severe asthma exacerbations are a major cause of intensive care unit admissions in children, leading to
significant healthcare burden in the United States. While there are clear guidelines for first-line treatment, the
benefit of non-invasive ventilation (NIV) remains unknown for children who fail to respond to the first-line
treatment. Bilevel Positive Airway Pressure (BPAP) is a type of NIV that may be an important second-line
therapy for managing severe asthma exacerbations in children but has not been sufficiently studied. Our
ultimate goal is to determine if early, emergency department (ED) initiation of BPAP for at least two hours
decreases critical care resource use and is safe in children with severe asthma exacerbations. As a step
toward this goal, the aims of the proposed study are:
Specific Aim 1: To develop a consensus-derived protocol for ED BPAP administration and the use of asthma
therapies for children with severe asthma exacerbations among sites that may participate in the definitive trial
and among whom practice variation exists. We will use a consensus decision-making model to create a
protocol for ED BPAP use and other asthma therapies.
Specific Aim 2: To determine a primary outcome measure for the definitive study of early ED BPAP in children
with severe asthma exacerbations that reflects critical care resource use. We will use a Delphi method to gain
consensus across sites, with measures to be evaluated including, but not limited to: intensive care unit (ICU)
admission rate, ICU length of stay, duration of BPAP use, and duration of continuous albuterol.
Specific Aim 3: To demonstrate the feasibility to enroll sufficient patients, adhere to an ED protocol for BPAP
use for at least 2 hours, and complete other key study procedures for a subsequent multicenter randomized trial
comparing early ED BPAP to no BPAP for children with severe asthma exacerbations. We will conduct a
feasibility RCT that aims to mirror a subsequent multicenter trial in design, population, intervention arms,
procedures, and outcomes assessed.
The study will be conducted within the Pediatric Emergency Care Applied Research Network (PECARN). The
results will inform the definitive trial of early use of ED BPAP in children with severe acute asthma. The
definitive RCT will potentially have a tremendous benefit to both individual patients and the healthcare system.

Public health relevance
PROJECT NARRATIVE Severe asthma exacerbations in children result in a substantial healthcare burden in the United States, often leading to pediatric intensive care unit admissions. Early Bilevel Positive Airway Pressure (BPAP) use may be a potentially important second-line therapy for managing severe asthma exacerbations in children, but its effectiveness and safety have not been adequately studied. The proposed study aims to develop a consensus protocol for BPAP administration, identify an appropriate critical care resource use outcome measure, and demonstrate the feasibility of enrolling a sufficient number of patients for a subsequent multicenter randomized controlled trial comparing early emergency department BPAP to no BPAP for children with severe asthma exacerbations.